Investigating Pathogenic Mechanisms of Frontotemporal Dementia Caused by Mutations in CHMP2B and TBK1

ABSTRACT
Frontotemporal dementia (FTD) is a progressive neurodegenerative disease associated with focal atrophy of
the prefrontal and/or temporal lobes. FTD is the second most common form of dementia among people under
the age of 65. Many FTD-causing genes have been identified during the last decade, including CHMP2B,
GRN, C9ORF72, and TBK1. Some of these genes are also implicated in the motor neuron disease
amyotrophic lateral sclerosis (ALS), paving the way for in-depth mechanistic investigation of pathogenic
processes in both disorders. In order to reveal common pathogenic mechanisms in different forms of FTD, it is
critically important to investigate both common and rare genetic mutations. To this end, in this application, we
will focus on the effects of FTD-causing mutations in CHMP2B and TBK1 on the functions of the endosomal-
lysosomal and autophagy pathways, two closely linked cellular pathways for degradation of transmembrane
and intracellular cargos. We will take advantage of strengths of different experimental systems including fruitfly
Drosophila, mouse models of FTD and cortical neurons differentiated from CRISPR-engineered induced
pluripotent stem cells (iPSCs). This multidisciplinary approach will greatly enhance our understanding of
pathogenic mechanisms of FTD and reveal novel targets for therapeutic intervention.

Public health relevance
Program Narrative To understand pathogenic mechanisms of frontotemporal dementia and related disorders, we will use a combination of genetic, molecular and cellular approaches in mouse and Drosophila models as well as induced pluripotent stem cell models to perform a series of experiments. The proposed mechanistic studies will contribute to the development of therapeutic avenues for these insidious disorders.